Investigating the role of locus coeruleus in conditioned cocaine-stimulus control of attention

Project Summary/Abstract
Salient environmental stimuli can capture attention and drive behavior; this process, vital for guiding
adaptive behavior, is called stimulus control. Stimulus control can become maladaptive in disease states, such
as cocaine addiction, where cocaine-associated stimuli can wield undue influence and disrupt ongoing preferred
behavior (i.e. occupational or social activities) and efforts to remain drug-free. While altered stimulus control is
well-understood to contribute to cocaine addiction, the neural mechanisms underlying this process are poorly
understood. The locus coeruleus (LC) is a neural structure, which modulates attention, sensation, and behavioral
control and is strongly effected by cocaine. Thus, the LC may be at the center of maladaptive stimulus control in
cocaine addiction. Stimulus encoding in LC and downstream sensory systems is known to be critical for stimulus-
guided behavior although it is not known if cocaine-associated stimuli are encoded in these systems. The
research plan proposed in this NRSA will elucidate the role of LC in encoding an auditory cocaine-stumulus and
examine whether there is a causal role for LC in mediating control of behavior by this stimulus. We will employ
a behavioral paradigm in rats which assesses stimulus control of water-reinforced behavior by an auditory
cocaine-stimulus. Aim 1 will use cellular resolution calcium imaging and electrophysiology to examine neural
correlates of stimulus control in the LC and auditory brainstem respectively. Aim 2 will use a chemogenetic
approach to selectively inhibit LC activity during acquisition or expression of conditioned stimulus control by a
cocaine-stimulus in order establish a causal role for LC in these processes. Combined, these experiments have
the potential to inform therapies aimed at targeting LC to attenuate maladaptive stimulus-driven behavior in
cocaine addiction.
Furthermore, the proposed fellowship will provide me with a strong foundation for a career as an
independent investigator focused on the neurobiological and behavioral underpinnings of addiction. The training
environment described in this proposal will incorporate faculty-student mentorships and collaborations aimed at
providing me with scientific training across the domains central to this project including LC physiology, calcium
imaging techniques, and sensory processing. Additionally, the training plan will provide me with professional
training which will prepared me for my future as I establish my own independent research program. As a whole,
this Fellowship has significant potential to produce both scientific findings relevant to treatment of addiction and
also a scientist well-equipped to become an outstanding member of the addiction research community.

Public health relevance
Public Health Relevance Statement Cocaine use disorder is a disease with significant individual and societal costs and few effective treatment options. Understanding the mechanisms which underlie behavioral control in cocaine addiction and contribute to relapse will inform novel therapeutic strategies which seek to prevent relapse and improve recovery rates.